BLR&D Research Career Scientist Award

The Peachey lab is focused on the outer retina, to understand the biology that underlies the initial stages
of the visual process and to identify genetic mutations associated with visual disorders. The first research
area combines the power of mouse genetics with electrophysiological, anatomical and biochemical assays.
Transgenic, systemic knockout and conditional knockout models allow the expression of a target to be
manipulated and the effect of that manipulation evaluated. Some projects conducted during the most
recent RCS award (2015-date) are highlighted here: (A) To better understand the rod and cone visual
cycles by which photoreceptors regain sensitivity following bright light exposure the CDA-2 program of
Philip Kiser utilizes pharmacological blockade of known visual cycle components (e.g., RPE65) in mouse
mutants lacking proteins such as DES1 that have been proposed as playing key roles. (B) To clarify the
metabolic processes that support photoreceptor function, a recent VA Merit Review supported studies of
mice lacking the ability to transport glucose (by targeting GLUT1) or lactate (by targeting basigin) across
cell membranes of rods, cones and the retinal pigment epithelium (RPE). (C) To understand the role of
retinoschisin (RS1) we worked with a panel of Rs1 mutants to clarify the disease phenotype. Based on the
severe phenotype, a new R01 focuses on the earliest stages of development in the mouse models and uses
psychophysical assays to determine whether RS1 mutations result in incomplete photoreceptor
development. (D) Forward genetics is used to develop new mouse models for vision research, in work
supported by a subcontract to Jackson Laboratory. We collaborate through design of ocular screens, gene
mapping and defining the retinal phenotype. To date, this collaboration has developed >20 mutants
involving almost as many genes. Notably this collaboration has led to the identification of two human
disease genes, including CTNNA1 during the most recent RCS award.
The Peachey lab has a long-standing interest in defining the genetic risk profile for age-related
macular degeneration (AMD). This began as a Merit Review in the early 2000’s focused on candidate
genes, an effort that developed into our serving as a site within the International Age-Related Macular
Degeneration Genetics Consortium (IAMDGC). During the most recent RCS award, the IAMDGC
published the most comprehensive assessment of AMD genetics to date. With the advent of the VA
Million Veteran Program (MVP), during the most recent RCS award we submitted a successful
application to conduct the first multi-ethnic analysis of AMD genetics. After defining an accurate ICD-
code based algorithm to identify AMD Cases and Controls without AMD, in the absence of gold-standard
ocular imaging results, we conducted genome wide association studies (GWAS) in MVP for European-
American (EA), African-American (AA) and Hispanic-American (HA) Veterans. The EA GWAS
replicated and extended the IAMDGC results. When coupled with IAMDGC data and analysis of other
databases, we identified a number of new AMD risk loci. Perhaps more important, we noted marked
differences in the AMD risk profiles of EA as compared to AA and HA Veterans. A newly funded Merit
Review will extend this successful approach to conduct additional genetic studies of ocular conditions
that are relevant to the Veterans Health Administration based on their prevalence. In each case, we will
validate a Case-Control algorithm and then move to a trans-ethnic genetic analysis. For some conditions,
we will conduct the first analysis that compares genetic risk across ethnic groups. For other conditions,
this will be the first genetic analysis ever conducted. A better understanding of ocular diseases such as
AMD, glaucoma, cataract, or diabetic retinopathy is an important step towards treatments to slow/halt
disease progression, and possibly reduce healthcare costs.

Public health relevance
The Peachey lab focuses on outer retinal biology and disorders that impact the function of rod and cone photoreceptors, which initiate vision. The power of mouse genetics, whereby the activity of specific genes of interest can be controlled, is used to understand fundamental aspects of the visual system, to define mouse models of human retinal diseases, and to evaluate experimental therapies in these models. The Million Veteran Program (MVP) biobank is used for studies of human genetics, where genes that confer susceptibility to an eye disease such as age-related macular degeneration (AMD) are identified and compared across the different ethnic groups that comprise the Veteran population. This information is important towards development of treatments that will maintain useful vision by slowing or halting disease progression, and towards the reduction of healthcare costs associated with these conditions.